National Food and Nutrition Analysis Program (NFNAP)

Specific Aim 1. Conduct an ongoing monitoring program for nutrients and other bioactive components in key foods that are major contributors of nutrients to the U.S. diet; Specific Aim 2. Develop and maintain databases for high priority foods consumed by U.S. ethnic sub-populations; Specific Aim 3. Develop and maintain new databases for nutrients and bioactive food components of emerging scientific interest;and Specific Aim 4. Develop and maintain a validated database for ingredients in dietary supplements. The aims of NFNAP will include: (a) identification of major contributors of nutrients and other compounds;(b) assessment of existing data quality for those contributors;(c) development of statistically-based nationwide sampling plans;(d) analysis of sample units using valid methodology with rigorous quality control;and (e) dissemination of nationally representative estimates for means and variability for foods and dietary supplements to the scientific community through databases and published research.